Spatiotemporal mechanisms of in vivo axon initiation and targeting during development

Project Summary (From Parent Award) The nervous system regulates many aspects of animal behavior and physiology, and its function relies on the generation of intricate networks of cellular connections. Failure to establish or maintain the proper connections can have profound health consequences, including intellectual and developmental disabilities, requiring that robust developmental mechanisms exist to ensure their precise organization. A common organizational motif innervous systems is the topographic map, in which the spatial relationships of neurons in a projecting field matches the spatial organization of the target field. By leveraging the optical, embryological and genetic accessibility of the zebrafish, we have discovered a novel temporal mechanism of topographic map formation that is different from existing “chemoaffinity” models that involve the molecular matching of spatial coordinates.Vagus motor axons emerge sequentially, with anterior axons emerging several hours earlier than posterior axons. In a parallel temporally regulated process in the head periphery, pharyngeal arches appear in an anterior-to-posterior appearance sequence. The outgrowing vagus axons then innervate the pharyngeal archessequentially from anterior to posterior, resulting in a topographic map in which anterior neurons innervate moreanterior targets and posterior neurons innervate more posterior targets. In this application, I propose to investigate the molecular mechanisms underlying these two parallel temporal processes. In Aim 1 I will determine how axon initiation is regulated at the cellular level in vivo, and will identify the differentially expressed genes that promote axonogenesis in anterior vagus neurons and/or delay it in posterior neurons. In Aim 2 I will investigate the role of the motor neuron chemoattractant HGF as the sequentially expressed pharyngeal arch attractant that is required for vagus topographic mapping. This work will establish new mechanisms that regulate axon specification and targeting, and will elucidate how the coordinated regulation of temporal developmental events can guide the development of complex topographic maps in vivo.

Public health relevance
Project Narrative (From Parent Award) This work aims to identify developmental principles guiding nervous system organization by elucidating how axon formation and targeting are regulated to promote topographic patterning. It will examine a novel mechanism of topographic patterning by the zebrafish vagus nerve in which timing of axon formation determines axon target choice. Specifically, I will discover the spatially regulated mechanism that controls axon initiation timing in vagus motor neurons, and the spatiotemporal dynamics of chemoattraction that controltheir sequential innervation of the pharyngeal arches.